AAV-mediated Müller glia reprogramming to early-stage retinal progenitor cells

Early-stage and late-stage retinal progenitor cells (RPCs) selectively generate retinal neurons in
discrete temporal windows over the course of retinal development. Müller glia (MG), and late-stage RPCs have
similar gene expression profiles and express many shared transcription factors (TFs) that repress proliferative
and neurogenic competence. Upon retinal injury, many of these TFs are downregulated in MG, while TFs that
drive reactive gliosis are upregulated. This process is necessary to activate neurogenic competence in fish and
amphibians. However, MG in mammals lack neurogenic competence, and TFs that maintain quiescence are
rapidly re-expressed following injury. We have identified key regulators of proliferative and neurogenic
competence in both RPCs and MG through multiomic analyses. I am now exploring the possibility that a single
AAV-based reagent can be used to reprogram MG to early-stage RPC-like cells that generate early-born
retinal cell types, including cone photoreceptors, in situ. I hypothesize that MG can be reprogrammed to gain
proliferative and neurogenic competence in mammals by disrupting the function of TFs that promote late-stage
RPC identity and are also expressed in adult MG. Furthermore, I anticipate that overexpression of TFs that
promote early-stage RPC identity in MG-derived progenitors may promote generation of early-born retinal cell
types (Fig 1B). Finally, by combining these overexpression and loss of function approaches with
overexpression of TFs that promote photoreceptor specification, I expect to be able to generate substantial
numbers of early-born cone photoreceptors. I propose two aims to address this hypothesis. Aim I: Alter retinal
development trajectory and reprogram adult MG using overexpression of full-length and dominant-negative
constructs of candidate TFs. Multiplexed single-cell (sc)RNA-seq analysis will be used to identify constructs
that promote proliferative and neurogenic competence in electroporated late-stage RPCs and transduced adult
MG. Immunohistochemistry will be used to validate findings from the scRNA-seq data. This aim will allow for
the functional characterization of TFs that regulate the transition between early and late stages of
developmental competence in RPCs, as well as the transition of MG from a quiescent to a neurogenic state.
This aim will also identify constructs that promote the production of early-born cell types, including cone
photoreceptors, in neonatal retinal explants and mature MG. Aim II: Overexpression of Prdm1 in
reprogrammed adult MG to drive cone photoreceptor formation. Prdm1 is selectively and strongly expressed in
photoreceptor precursors and stimulates photoreceptor differentiation. Overexpression of Prdm1 may induce
reprogrammed MG to produce early-stage RPC-like cells that are neurogenic and specifically generate mature
cone photoreceptors. This project has significant potential to contribute to the development of novel gene
therapies for photoreceptor dystrophies, including age-related macular degeneration, Stargardt's disease, and
retinitis pigmentosa.

Public health relevance
Photoreceptor dystrophies and age-related macular degeneration cause permanent loss of cone photoreceptors and lead to blindness, but there are few to no treatment options for these diseases. In fish and amphibians, Müller glia cells in the retina proliferate in response to retinal damage, and their daughter cells differentiate to replace lost retinal neurons. In this project, I propose to use AAV technology to overexpress genes that promote early-stage retinal progenitor cell identity and repress genes associated with Müller glia cell identity, which may induce adult mouse Müller glia to proliferate and produce new cone photoreceptors.